Dynamic entanglements: the functional role and mechanistic basis of inter-individual neural synchrony

PROJECT SUMMARY
The vertebrate brain has evolved to enable complex social interactions, essential for survival. Brains of animals
engaged in a shared social interaction exhibit inter-brain synchronization of neural activity, detectable at several
levels of analysis. It remains unclear what aspects of social behavior are driven by these intriguing inter-brain
dynamics. We propose to develop and apply a revolutionary set of molecular-genetic and optical tools to record
and manipulate neural activity wirelessly and simultaneously in multiple interacting animals from distantly related
rodent species across a broad spectrum of sociality. These studies include evaluation of synchrony parameters,
along with causal imposition of synchrony to drive social behaviors and attachment. We aim to leverage novel
functional genetic approaches to identify the cellular and subcellular basis and neuromodulatory mechanisms
that underlie the emergence and strengthening of synchrony. This project will revolutionize our concept of the
social brain, placing a multi-dimensional emphasis on neural activity within and across interacting brains, linked
by the non-corporeal bonds of shared life. This is critical for understanding the full breadth of human sociality,
identity, neurotypical and atypical behavior, as well as mental and physical health.

Public health relevance
PROJECT NARRATIVE Correlations in neural dynamics across the brains of interacting individuals are an emergent and highly conserved property of social interactions, but the functional relevance of these correlations remains enigmatic. In this proposal we will use a comparative multi-species approach, combining state-of-the-art wireless technological advances and cellular/subcellular resolution imaging with pioneering molecular-genetic tools to decipher the biological mechanisms that enable neural synchrony and unequivocally define its function. By moving beyond a correlative understanding of this intriguing emergent neural property, we will determine its role in successful social interaction and attachment, a finding with transformative implications for the manipulation of these dynamics in a therapeutic context.